Substantia nigra circuits in instrumental action

Project Summary / Abstract
Degeneration of dopamine neurons in the substantia nigra pars compacta (SNc) and resulting
pathophysiology in basal ganglia circuits are central to the core motor impairments in Parkinson's Disease
(PD). A variety of non-motor symptoms also are highly prevalent in PD, including motivation-related deficits
manifesting as apathy, fatigue, and depression, which have significant negative impacts on quality of life for
patients and caregivers. However, we still have limited understanding of how nigrostriatal dopamine
contributes to specific aspects of motivated behavior spanning action selection and invigoration, particularly in
the context of cost-benefit decisions entailing effortful reward seeking. Recent work has increasingly
highlighted a remarkable diversity of midbrain dopamine neurons, and indeed some subpopulations of SNc
dopamine neurons are preferentially vulnerable in PD. Defining the circuits regulating distinct nigrostriatal
dopamine projections and determining their subtype-specific roles in motivated behavior will address critical
knowledge gaps and represents important first steps toward developing more effective and specific treatments
for disorders such as PD. Our preliminary data suggest that manipulating afferent inputs can drive highly
divergent responses in different nigrostriatal dopamine projections. In particular, stimulating subthalamic
nucleus glutamatergic neurons drives diametrically opposed responses in nigrostriatal dopamine projections to
distinct striatal subregions. Additionally, stimulating different populations of descending striatonigral projections
evokes opposing patterns of dopamine release within the same region of the striatum. However, the circuit
interactions underlying these divergent effects remain unknown. Beyond its recognized role as a major basal
ganglia output nucleus, the substantia nigra pars reticulata (SNr) provides critical inhibitory regulation of SNc
dopamine neurons, and we propose that this may differ between dopamine neuron subtypes and mediate their
divergent responses to other basal ganglia afferent inputs. Given the anatomically segregated projections of
SNc dopamine neuron subtypes to different striatal subregions, we will test the hypothesis that these dopamine
subpopulations differentially contribute to dissociable aspects of effortful reward-seeking behavior. The major
goals of this proposal are therefore 1) to characterize how SNr GABA neurons regulate divergent nigrostriatal
dopamine pathways and potentially mediate pathway-specific responses to distinct afferent inputs, and 2) to
determine the roles of these SNc dopamine neuron subpopulations in effort-based decisions and instrumental
action invigoration. Collectively this research program will yield important advances in understanding basal
ganglia circuit regulation of diverse dopamine neuron subtypes and their contributions to motivated behaviors
often impacted in PD.

Public health relevance
Project Narrative In addition to core motor impairments, Parkinson's Disease often entails motivation-related symptoms such as apathy and depression. However, we lack a detailed understanding of the neural circuit interactions underlying how we select and perform effortful actions in the pursuit of our goals. By characterizing circuit mechanisms regulating the activity of different nigrostriatal dopamine projections and examining how these dopamine neuron subpopulations contribute to effortful reward-seeking behavior, this research program will yield critical new insights into the cell types and circuits supporting motivated behavior.